ATR Dependency as a Novel Therapeutic Target in Lethal RB Deficient ProstateCancer

Metastatic prostate cancer (mPCa) is incurable and responsible for most PCa associated mortality. Androgen deprivation therapy (ADT) is the primary line of treatment for mPCa. ADT initially extends survival but is not curative as the patient’s tumor acquires castration resistance (mCRPC). A majority of mCRPC remain dependent on the function of the androgen receptor (AR), though a subset of cases (approximately 20%), of resistance mechanisms are independent of AR activity (CRPC-AI). CRPC-AI adapt to ADT via lineage plasticity rather than a result of resistant mutations, adopting a phenotype no longer reliant on AR expression and signaling. These tumors may display neuroendocrine features, a stem or basal cell-like phenotype, altered kinase signaling, and characteristic epigenetic alterations. Recently, we and others have characterized the molecular landscape of CRPC-AI and have identified and validated new therapeutic targets and drivers, including loss of Retinoblastoma-1 (RB1) and TP53, and induction of specific epigenetic/reprogramming factors such as (Enhancer of Zeste Homolog 2) EZH2, DNA Methyltransferase 1 (DNMT1) and SOX2. Additionally, our work validated the importance of EZH2 reprogramming downstream of RB1 loss, driving lineage plasticity and resistance to ADT. Moreover, inhibition of EZH2 enabled lineage reversal and re-sensitized RB loss prostate cancer to ADT. Importantly, recent data from patients with mCRPC identified RB genetic aberrations as the strongest predictor of poor outcome. These data implicate RB as a dominant molecular mechanism driving lethal prostate cancer. Currently there is no therapeutic option to provide durable response in patients with RB loss-of-function (LOF). Therefore, there is a critical need to delineate downstream effectors of RB LOF so that therapeutic targets can be identified and validated in clinical trials. Specific to this application, our functional genomic screen has identified dependence on DNA damage repair kinases – specifically – ATR. This proposed work is innovative because it will provide deeper mechanistic knowledge of drivers of RB deficient prostate cancer and therapeutic options towards a currently untreatable phenotype. Through this work we will validate the ability of DDR kinase targeting to exacerbate DDR deficiency and to generate hypersensitivity in RB-deficient prostate models (Aim 1) Validate P53 dependence to ATR inhibition in RB-deficient prostate cancer models and alternate therapeutic targets (DNMT1 inhibition) independent of P53 to induce immunogenicity, and (Aim 3) Evaluate synergy of DNMT1 inhibition and immune checkpoint blockade therapy in pre-clinical NEPC prostate cancer mouse models in vivo. Ultimately, this information will enable us to gather sufficient preliminary evidence to make a compelling case to commence investigator-initiated multi-center clinical trials.

Public health relevance
PROJECT NARRATIVE Due to inevitable therapeutic resistance driven by RB deficiency, prostate cancer remains a lethal disease, so is critical to delineate mechanisms underlying RB deficient driven therapeutic resistance to implement novel treatments that will extend patient survival and quality of life. We hypothesize that RB deficient prostate cancer acquires dependence on ATR kinase activity. We will test this hypothesis and determine novel treatment strategies for RB deficient prostate cancers by targeting ATR, and validate the potential of ATR inhibition as monotherapy and in combination with carboplatin, EZH2 inhibition and check-point immunotherapy.